Exploiting Unconventional Building Blocks in Chemical Synthesis

Project Summary/Abstract
The central objective of this application is to harness unconventional synthetic
building blocks for the development of new, reliable, and efficient, methodologies.
These methodologies are intended to enable the construction of stereochemically-rich
scaffolds, including those seen in naturally occurring small molecules and medicines.
The development of new methods and the syntheses of complex small molecules
continues to be vital areas of research. Most medicinal agents on the market are
prepared by organic synthesis, including the large majority of all new drugs that have
become available over the past several decades. The chemical structures of new drug
entities are becoming increasingly complex, providing an increased need for chemists to
develop new methods that can reliably build intricate structures.
Our proposal involves strained intermediate chemistry, with a particular focus on
pi-bond containing compounds that are geometrically distorted. The distortion leads to
heightened reactivity, which we ultimately leverage to access complex scaffolds and
provide new synthetic strategies. We will develop methods associated with transient
intermediates that display bent geometries, such as cyclic allenes and cyclic 1,2,3-
trienes, that otherwise prefer linear geometries in the acyclic form. Alkenes that are
geometrically distorted from an ordinary trigonal planar geometry due to twisting or
pyramidalization, including anti-Bredt olefins, will be pursued. Lastly, the scope and
limitations of these methodologies will be probed in the context of enantioselective
natural product synthesis. Collectively, our efforts will establish the concept that
historically avoided strained intermediates that possess geometrically-distorted
structures can be strategically exploited to assemble complex molecular architectures.

Public health relevance
Project Narrative The central objectives of this application are: (a) to develop new, reliable, and efficient, methodologies that enable the construction of stereochemically-rich scaffolds and (b) to achieve the concise chemical syntheses of naturally occurring small molecules that possess intricate chemical structures. Central to these efforts is the strategic use of unconventional strained intermediates to introduce structural complexity. The results of these efforts should lead to the development of new strategies and tools for the preparation of various molecules of importance, including medicines.